ShEEP Request for NanoString GeoMx Digital Spatial Profiling System

This application is to acquire a GeoMx™ Digital Spatial Profiler System (NanoString Technology, Inc.) on
behalf of the BLRD/CSRD FRACTURE CURB Collaborative Merit Review Program (CMRP) and the San
Francisco VA Medical Center (SFVAMC) Skeletal Biology and Biomechanics (SBB) Core facility, which was
originally established in 2003 through funding of BLRD Research Enhancement Award Program and later a
BLRD Program Project. This core is also one of 3 core facilities in the NIH (P30) Core Center for
Musculoskeletal Biology and Medicine (CCMBM). This self-reliant Core had supported basic and translational
research for more than 100 VA, NIH, and DoD-funded projects in endocrinology, orthopedics surgery,
neurobiology, nephrology, radiology, pulmonology, dermatology, immunology, and cardiothoracic surgery,
and enabled numerous new collaborative projects within the greater UCSF research community and more
recently nationwide VA stations. This Core has been designated in 2022 as the Molecular and Histological
Core for the newly awarded FRACTURE CURB CMRP, which includes 5 independent skeleton-centric Merit
Review projects across 4 VA stations.
Comprehensive transcriptomic and proteomic profiling techniques are essential for understanding of
changes in transcriptional and translational regulation, respectively, in tissues subjected to diseases, drug
treatments, or genetical manipulations. Advances in high-throughput ensemble or single-cell RNA sequencing
and liquid chromatography Mass Spectroscopy (LC-MS) for tissues or isolated cells have filled some of these
technical gaps. However, latter technologies lack resolution to delineate spatial effects and cell-specific
actions on gene expression that have been proven critical in regulations of cellular functions at cellular and/or
molecular levels. To overcome the latter pitfalls, the SFVAMC-SBB core successfully installed a state-of-the-
art GeoMx™ DSP System in 2021 to permit high-throughput in situ proteomic and transcriptomic profiling in
tissue sections in a spatially-defined and cell type-specific manner. After several months of intensive protocol
development and testing, the DSP proteomic and whole transcriptomic assay (WTA) profiling service were
sequentially rolled out to local VA and UCSF community in late 2021. Initial responses to the soft opening of
these new services have been overwhelming. In the past 12 months, we have successfully completed 60
DSP assays. Some of the results have been used as preliminary data for grant applications, including 5
awarded Merit Reviews under the FRACTURE CURB CMRP and 3 NIH applications which have recently
received fundable scores (based on 2022 institutional paylines). Given the initial successes, requests for the
DSP services have substantially increased in the Fall of 2022 as such that the service backlog has been
extended to 6-8 weeks for the current projects in the queue. We anticipate the project turnaround time will be
further lengthened when the studies proposed in the 5 FRACTURE CURB projects and the 3 to-be-awarded
NIH projects are in full swing. Given the labor-intense and time-consuming natures of equipment setup and
protocol development, we intend to make these technologies available to other nationwide VA researchers
who do not have access to this technology to further fulfill the spirit of ShEEP. We will, therefore, request
another unit of the GeoMx™ DSP System to double the current spatial transcriptomic and proteomic profiling
capacity at SFVAMC-SBB Core for 3 specific goals. Frist, we will reduce the turnaround time of DSP service
to less than 3 weeks for ongoing projects. Second, we will dedicate 25% of machine time to develop protocols
for RNA and protein profiling in bone and provide the needed services to the 5 active and future additional
FRACTURE CURB CMRP projects. Third, we will develop workflow and infrastructure to enable DSP profiling
services to nationwide VA researchers who do not have access to this technology. We believe, by fulfilling
these 3 goals, our core DSP services will greatly enhance the VA research resources as a whole.

Public health relevance
The goal of this application is to adopt a critical technical platform for spatially-defined cell type-specific profiling of gene and protein expression to evaluate, with high fidelity and resolution, molecular changes in bone, skin, lung, cardiovascular, endocrine, kidney and brain diseases in order to advance our basic and translational biomedical research and to facilitate development of treatments for the diseases. Since molecular and cellular changes accompany and drive disease progression, this tool will not only facilitate translational studies using animal models and patients’ biopsies, but also provide a robust means in delineating pathological pathways that cause the diseases which afflict large populations of VA patients.